Molemolemo: Building Research Administration Excellence in South Africa

PROJECT SUMMARY
The growth of research activities at The Aurum Institute (Aurum) in Johannesburg, South Africa, and its
objective to engage in more primary research awards on the African continent, have highlighted the desire for
improved administrative oversight of NIH/NIAID grant awards and compliance with NIH funding policies. To
achieve the aims outlined in this application, we will work together with Vanderbilt University Medical Center
(VUMC) to receive advanced grants administration training and exposure to best business practices. VUMC
will assist in performing a mixed methods needs assessment of the research administration and management
environment at Aurum and generate an Action Plan that will identify training needs, prioritize processes, and
guide program implementation. VUMC will lead virtual training workshops on a variety of administrative topics
and will host a Grants Management Practicum to be attended by the two PIs. A major focus and output of the
collaboration with VUMC is the in-house development of a structured Grants Management Training Course for
non-US-based organizations, to be comprised of essential and elective modules. This will be the vehicle
through which we will ensure lasting impact of the training support offered through this grant. With technical
assistance and course materials from Vanderbilt, this program will be developed to enhance and improve
training in grants management and research administration. In the second year of the practicum at Vanderbilt,
Aurum administrators will create video training modules, which will be instrumental in rolling out a standardized
Grants Management Training Program across the different Aurum entities in South Africa and elsewhere in
Africa. In addition to recorded modules, the Aurum grants management team will regularly, at a minimum twice
a year, lead both virtual and in-person classroom training workshops per the developed training curriculum on
a variety of administrative topics ranging from proposal development through award closeout. The applicable
mandatory modules will become part of the on-boarding program for new staff and we will continue to develop
and update the training course as and when needed. The proposed development award will enable the
creation of a high-quality research administration environment at the Aurum Institute, its affiliates, and
collaborating partners, that is knowledgeable and compliant with the fiscal and management standards of
sponsored research.

Public health relevance
PROJECT NARRATIVE The recent awarding of the Clinical Trials Unit grant (1UM1AI154463) to The Aurum Institute and its desire to attract more primary research awards presents an opportunity for Aurum to invest in the administrative capacity of research administration, to create a high-quality research environment in which both scientific and administrative standards are upheld. The proposed program expands the long-standing collaboration between the Aurum Institute and Vanderbilt University Medical Center to include capacity building for excellent pre- and post-award management of NIH/NIAID-funded research projects, resulting in the development of a Grants Management Training Course for non-US-based organizations. This standardized training course will be used to further capacitate researchers and research administrators/grants managers across the different country offices and Aurum-affiliated entities and partner organizations.